Investigation of Mechanical Allodynia Circuitry by the Nature of the Injury

Abstract
Persistent pain continues to be a major clinical problem due to its high prevalence and lack of adequate treatment
options. This proposal is focused on understanding the neuronal populations and central sensitization
mechanisms that underlie mechanical allodynia in the dorsal horn. Mechanical allodynia is a common and
debilitating condition in which normally innocuous touch or movement become painful after an injury. The dorsal
horn is a major site for the integration of somatosensory information and for injury-induced circuitry changes that
give rise to mechanical allodynia. In our previous studies to elucidate excitatory populations that convey
mechanical allodynia, we identified a new concept for how the circuitry is organization. Specifically, we showed
that rather than a single circuit, as it was previously modeled, the excitatory circuitry is composed of overlapping
combinations of excitatory populations that differ depending on whether the injury is inflammatory or neuropathic
in nature. Work here, will identify the excitatory circuitry for polyneuropathic injuries modeling type I and I diabetes
and chemotherapeutic neuropathy. Preliminary data indicate that the previously identified excitatory populations
are dispensable for this type of injury. Work here will also examine the inhibitory circuitry that gates mechanical
allodynia induced by the three types of injuries. There are three major inhibitory populations that have been
implicated in gating mechanical allodynia but their locations within the network and the mechanism of gating
remain unclear. Preliminary data included here provides evidence for a fourth population that may specifically
gate inflammatory injury induced mechanical allodynia. Aim 1 is focused on identifying the excitatory populations
that convey mechanical allodynia as a function of injury type, the synaptic connectivity between them and
mechanisms of sensitization. Experiments will utilize spatial transcriptomics, chemogenetics, rabies- and AAV1-
mediated circuit tracing, patch-clamp electrophysiology with campari2 and cell targeted apex2 proximity labeling
for proteomic analyses. Aim 2 is focused on identifying where in the network, the four inhibitory populations
gate mechanical allodynia and in which type of injuries. What are the excitatory neurons that are directly gated
and what are the gating mechanisms. Experiments will utilize chemogenetics, patch clamp electrophysiology
and apex2 proximity labeling with proteomic analyses. Our work in the last grant period planted the seeds for
the analysis that we will perform here. Work here will provide the essential framework of the dorsal horn
mechanical allodynia network in the context of injury type, including the combinations of excitatory neurons that
convey mechanical allodynia, the combinations of inhibitory neurons that gate mechanical allodynia. We will
also gain insight into the synaptic connectivity and cell- and synapse- specific mechanisms of central
sensitization for both the excitatory and inhibitory populations for different injury types. This framework can be
used to best study how primary afferents and supraspinal inputs impact the induction and maintenance of the
dorsal horn mechanical allodynia network. It will also reveal important new therapeutic targets.

Public health relevance
Narrative The neural circuits that induce and maintain mechanical allodynia, a common and debilitating pain condition brought on by nerve and tissue damage, are poorly understood and treatment options remain limited. Efforts outlined in this grant application will take advantage of our recent progress interrogating the dorsal horn network for mechanical allodynia. A more comprehensive understanding of how the dorsal horn encodes and gates mechanical allodynia induced by different types of injuries will significantly improve our ability to identify effective pain therapies.